Mechanistic re-evaluation of fibroblast growth factor homologous factors in the heart

Abstract
Cardiac ion channels are tightly regulated—in abundance, subcellular location, turnover, and activity—to
control the electrical signaling that drives heart muscle contraction. Any perturbation of this regulation can lead
to arrhythmogenic sudden death. Most studies of how ion channel dysfunction contributes to pathophysiology
have focused on defects of the channel pore-forming subunits. Contributions of channel auxiliary subunits are
understudied and complicated by alternative or additional roles for this set of proteins. Here, we focus on
fibroblast growth factor homologous factors (FHFs), proteins that bind directly to voltage-gated sodium channels
(VGSCs) including the cardiac NaV1.5 channel and that are implicated in life-threatening arrhythmias. Studies
on FHFs in heart have focused almost exclusively on how they regulate NaV1.5 via direct binding the channel's
cytoplasmic C-terminus. The goal of this proposal is to expand knowledge of how FHFs influence cardiac
physiology and how variants contribute to arrhythmias, thus providing a platform for targeted therapies. Our
preliminary data uncover three unexpected aspects of FHF function in heart: 1) FHFs regulates VGSCs
independent of channel interaction; 2) FHFs regulate trafficking and membrane targeting of multiple cardiac
channels via control of microtubule stability (we focus on connexin43 [Cx43]); 3) FHFs affect adrenergic signaling
to channels independent of ion channel interaction. We propose to define the underlying mechanisms using a
novel structurally guided approach that generates an FHF incapable of binding NaV1.5 and by exploiting
unbiased proteomic analyses using protein proximity labeling in cardiomyocytes in the following Aims:
Aim 1: Test the hypothesis that FGF13 confers VGSC regulation by affecting local membrane
cholesterol. FGF13 is the main FHF in rodent hearts. Our preliminary data offer insight into how FGF13 affects
NaV1.5 via regulation of local accessible membrane cholesterol, a mechanism independent of channel binding.
Among other implications this aim may explain the vulnerability of subjects with Brugada syndrome to
arrhythmias during febrile illnesses.
Aim 2: Test the hypothesis that FGF13 stabilizes cardiomyocyte microtubules and thus regulates ion
channel trafficking through regulation of MAP4. Focusing on Cx43 trafficking, we show that ablation of
FGF13 in mice destabilizes microtubules and mislocalizes Cx43 in ventricular cardiomyocytes via effects on
MAP4, a key regulator of microtubules in cardiomyocytes. We will investigate the underlying mechanisms of this
additional NaV1.5-binding independent effect.
Aim 3: Test the hypothesis that FGF13 regulates adrenergic responses in cardiomyocytes. Exploiting
an unbiased proteomic screen, we uncover that FGF13 affects adrenergic regulation of NaV1.5 and CaV1.2 Ca2+
channels. Building on our unbiased discovery platforms, we propose to determine the mechanisms by which
FGF13 regulates this critical cardiomyocyte signaling pathway.
Together, these Aims propose to expand an understanding of FHFs in cardiomyocyte biology and more
generally uncover mechanisms for how ion channel auxiliary subunits regulate their targets.

Public health relevance
Project Narrative Cardiac ion channels are tightly regulated—in abundance, subcellular location, turnover, and activity—to control the electrical signaling that drives muscle contraction. Channel dysregulation— because of perturbation of abundance, subcellular location, turnover, or activity—can lead to arrhythmias and consequent heart failure and/or sudden death. Here, we investigate previously unexplored roles in the heart of the fibroblast growth factor homologous factor set of auxiliary subunits.